Imaging Core

Massachusetts Alzheimer's Disease Research Center: Imaging Core
The Imaging Core of the Massachusetts Alzheimer's Disease Research Center (MADRC) supports and
performs imaging research to understand a variety of types of heterogeneity in Alzheimer's disease and
Alzheimer's disease related disorders (AD/ADRD) and accelerate progress towards a cure. We carry out
core functions in Aims 1, 2, and 3 marshaling resources to enhance the research mission through the
support and contributions to imaging components of MADRC-affiliated local and national research projects and
the development of uniform imaging protocols that contribute to novel efforts to understand heterogeneity, such
as the classification of MADRC Research Cohort participants into the "ATVN" (amyloid, tau, vascular,
neurodegeneration) biological research framework. In Aims 4, 5, and 6, we develop and implement new
strategies and accelerate progress towards a cure in our refinement and validation of novel PET and
structural and functional MRI methods. These innovative imaging methods are evaluated in the MADRC
Research Cohort, leveraging this deeply phenotyped cohort of participants spanning diverse AD/ADRD
diagnoses to make the process of innovation cost-effective (many participants have already been imaged and
so these measures can be used to facilitate strategic recruitment; e.g., of amyloid “positive” subjects) and
value-added (by comparing novel imaging measures with those we understand well already). In Aims 7 and 8
we build the future by providing expertise, education, training and data and software tools to faculty, trainees
and students for best practices in imaging research and by providing education to researchers, clinicians and
the public on the advances, utility and responsible interpretation of imaging data in AD and ADRD research
and ultimately clinical practice.